Microbial Dysbiosis in Pancreatic Cancer Initiation and Progression

Project Summary
Pancreatic adenocarcinoma is a devastating disease with a five-year survival of only 10%. The rise of
immunotherapy has led to breakthrough treatments in many cancers, like melanoma, drastically improving
survival outcomes. However, unlike malignant melanoma, we have seen minimal changes in survival for
pancreatic cancer because we still do not completely understand the regulators of immunity in this disease.
Bacterial dysbiosis is emerging as an accomplice to carcinogenesis and is associated with pancreatic
cancer progression and poorer survival. We found that gut bacteria can directly access the pancreas, and
pancreatic tumors harbor a unique microbiome. The tumor-associated microbiome regulates pancreatic
cancer progression by skewing tumor-infiltrating immune cells towards an immunosuppressive phenotype.
However, the exact mechanisms via which bacteria regulate immune cell function is still unknown.
Inflammatory signaling in cancer cells and stromal cells in the tumor microenvironment has been shown to
greatly regulate the immune cell infiltrate in pancreatic cancer. Our preliminary data suggests that
pathogenic bacteria can directly interact with pancreatic epithelial cells inducing proliferation and an
inflammatory response. Furthermore, we found that the presence of bacteria in tumors skews fibroblast
differentiation towards an inflammatory, tumor-promoting phenotype. In this proposal, we seek to
determine how tumor-associated bacteria modulate the epithelial and stromal compartments in the
pancreatic tumor microenvironment thereby aiding their ability to promote pancreatic cancer progression.
The overall goal of this application is to support my continued training and development to become an
independent investigator in microbiology and pancreas cancer biology. The career development plan is
based on formal didactic coursework, experiential learning, and mentored basic science training. I have
received generous support and protected time from my department and will work closely with my mentor
Dr. Marina Pasca di Magliano, PhD a respected and experienced pancreatic cancer biologist. I have also
constructed an advisory committee, with expertise in microbiology and bacteria-host interaction to further
my microbiology training while completing this project. The major themes of my research interests are
reflected in the Specific Aims of this proposal: (1) to determine the influence of tumor-associated bacteria
on pancreatic cancer cells (2) to determine their ability to activate and differentiate pancreatic stromal cells
and (3) to further characterize the mechanisms of pathogenicity unique to pancreatic cancer-associated
bacteria. Successful completion of these proposed experiments will delineate the mechanisms via which
microbes interface with non-immune cells in the tumor microenvironment, and provide insight into
therapeutic strategies for gut microbial modulation in treating pancreatic cancer.

Public health relevance
Project Narrative The tumor-associated microbiome regulates pancreatic cancer progression but the exact mechanisms via which bacteria regulate tumorigenesis is still unknown. The proposed work will (1) determine the influence of tumor-associated bacteria on pancreatic cancer cells, (2) determine their ability to activate and differentiate pancreatic stromal cells, and (3) characterize the mechanisms of pathogenicity unique to pancreatic cancer-associated bacteria. Knowledge gained from our proposed experiments will provide insight into therapeutic strategies for gut microbial modulation in treating pancreatic cancer.